Acute and chronic effects on skeletal muscle from alphavirus infection

Ross River (RRV) and Chikungunya (CHIKV) viruses are emerging pathogens that target the musculoskeletal
system and a major health concern as they cause explosive outbreaks in humans. RRV and CHIKV are
mosquito-borne enveloped RNA viruses that cause severe arthralgia, arthritis, myalgia and myopathy that
typically resolves within weeks of infection, although a significant fraction of RRV and CHIKV patients develop
debilitating chronic disease. While the etiology of virally-induced arthralgia and arthritis has been intensely
studied, the mechanisms underlying myalgia and myopathy are poorly understood. Our collaborative research
uniquely combines the expertise of a skeletal muscle biology lab (Gabrielle Kardon) and a viral pathogenesis
lab (Deborah Lenschow) to determine how RRV and CHIKV affect muscle structure and function to cause
myopathy and test if and how infection of myogenic cells drives acute and chronic disease. Using new mouse
models of RRV and CHIKV disease, recombinant versions of RRV and CHIKV to track infected cells, and
mouse genetic alleles to label and manipulate myogenic cells we will test two hypotheses. First, we will test
whether infection and cytopathic destruction of myofibers and a protracted regenerative response are the
cause of acute myopathy. Second, we will test whether mechanically compromised myofibers and functionally
and transcriptionally altered muscle stem stems are major causes of virally-induced chronic myopathy. Our
research will elucidate the mechanisms causing the acute and chronic myopathy that are key aspects of
increasingly common and debilitating RRV and CHIKV disease. In addition, our studies, which include
comparison to regeneration following hypercontraction (BaCl2) injury, will provide important insights into the
mechanistic differences between skeletal muscle recovery after pathogenic and acute sterile injury.

Public health relevance
Ross River (RRV) and Chikungunya (CHIKV) viruses are emerging pathogens that target the musculoskeletal system and a major health concern as they cause explosive outbreaks in humans. A major unknown in our understanding of RRV and CHIKV disease is how viral infection causes acute and chronic myalgia and myopathy, an important consequence of viral infection found in 90% of patients. Our research will determine what functional, structural, cellular, and molecular changes in muscle result from RRV and CHIKV infection and test whether infection of myogenic cells drives systemic acute and chronic disease.